Houston Area Molecular Biophysics Program

The Houston Area Molecular Biophysics Program (HAMBP) has guided and led research training in molecular
biophysics for PhD students in the Houston-Galveston area since 1989. A five-year renewal with one
additional slot (10 total) is sought to allow continued excellence and innovation in training outstanding students
interested in working at the cutting edges of this increasingly important field. Under the direction of the program
director and a steering committee with representatives from each of five graduate schools of the Gulf Coast
Consortia (Baylor College of Medicine, Rice University, University of Texas MD Anderson Cancer
Center/University of Texas Health Science Center-Houston, University of Texas Medical Branch at Galveston,
and University of Houston) the program provides didactic and seminar courses, two local annual research
conferences with trainee talks and poster sessions, monthly trainee meetings, professional/career
development seminars, attendance at national meetings, and annual presentation and review of trainee
research progress. All students are required to participate in training in the responsible conduct of research
and workshops in rigor and reproducibility. Mentors include 39 faculty members at six institutions, affiliated with
14 different departments and 4 interdepartmental graduate programs. These faculty have exemplary training
and research records, as well as strong research funding. They have trained 191 predocs and 229 postdocs
over the past 10 years, and continue to be active, with 106 predocs and 76 postdocs currently in their labs.
Our predoctoral trainees will have completed one year of study and have selected a major thesis advisor at
one of the participating institutions before joining HAMBP. Trainees are selected in a highly competitive
process from students whose projects in mentors' laboratories provide training in molecular biophysics. While
trainee selection is based on merit, the program is committed to enhancing diversity and has been very
successful in recruiting and retaining members of underrepresented groups. Research strengths include x-ray
crystallography, macromolecular NMR, cryo-electron microscopy, a wide range of spectroscopic and
microscopic techniques, single molecule methods, computational biophysics, membrane biophysics, protein
folding, nucleic acid structure and ultrastructure, thermodynamics, kinetics and mechanistic enzymology.
Supported students who complete the program publish an average of 3 papers from their thesis research,
including many in high impact journals, and go on to successful, research-focused careers in academia,
industry, government agencies, and private organizations. The heavy involvement of institutions of the Texas
Medical Center and the University of Texas Medical Branch at Galveston ensures that students are involved in
and exposed to research relevant to human health. The quantitative and interdisciplinary skills that are
emphasized in the program are critical for advancing biomedical research and making breakthroughs in our
understanding of human disease processes and in the design of new therapeutics and diagnostics.

Public health relevance
Project Narrative The Houston Area Molecular Biophysics Program prepares Ph.D. students for research applying the principles of physics to important medical problems and to the basic biology underlying medical research. Training in Molecular Biophysics and the quantitative and interdisciplinary skills emphasized in the program enable research careers leading to fundamental understanding of human disease and development of innovative approaches to diagnostics, therapeutics, and disease prevention. Biophysics provides tools used by all specialties in biomedical research and in medical practice.